Admin-Core-001

ADMINISTRATIVE, MENTORING AND EDUCATION CORE A: SUMMARY
The major goal of Phase 2 of COBRE funding of the Mississippi Center of Excellence in Perinatal Research
(MS CEPR) is to further the sustainability of an innovative, nationally recognized center of excellence in
perinatal research spanning the spectrum from adverse pregnancy to subsequent health outcomes in mothers
and offspring. More specifically, perinatal research encompasses the study of disease states that occur during
gestation and early post-natal development that result in long-term adverse consequences in the mother and
offspring across their lifespans. Research focuses on the integrative relationships and health disparities in
adverse pregnancy, pregnancy outcomes, and developmental programming of cardiovascular, renal,
metabolic and behavioral diseases. This is an important area for research especially in light of the increasing
evidence of long term health consequences brought about by adverse fetal environment, and subsequent low
birth weight. An adverse perinatal environment is thought to account at least in part for the development of
obesity, cardiovascular, renal, and behavioral diseases later in life for male and female offspring, and
predispose the mothers for increased risk of these diseases with aging. This is especially important for
Mississippi since we have one of the highest rates of preeclampsia, low birth weight, preterm labor, obesity,
cardiovascular, renal and metabolic diseases and hypertension in the United States. The addition of COVID19 and the complications associated with it further add to disproportionate levels of morbidity and mortality in
both our Caucasian and African American populations. Thus, Phase 2 of this COBRE will continue to improve
sustainability and research excellence in the MS CEPR by providing infrastructure and capacity for continued
building of a multidisciplinary, diverse group of basic, clinical and population scientists working on the common
synergistic theme of perinatal diseases and health disparities and to facilitate their collaborations. Specific
Aims of the Administrative, Mentoring and Education Core A are to provide leadership for all aspects of the MS
CEPR; coordinate and provide support for all Center-related activities; maintain and improve mentoring and
education programs for MS CEPR research project leaders (RPLs) or pilot project leaders (PPLs); interface
with the NIGMS, the University of Mississippi Medical Center (UMMC) administration, the UMMC Office of
Research and Sponsored Programs including Pre- and Post-Award Centers, the departments represented by
RPLs and PPLs; recruit, train, and mentor a diverse group of graduate students and postdoctoral fellows to
provide the next generation of perinatal researchers and to provide mentoring experience for RPLs and PPLs
as needed; organize networking meetings and seminars as well as meetings of the Executive Committee,
Internal and External Advisory Committees; and increase the number of investigators at UMMC who focus on
perinatal research by working with department chairs to hire new perinatal investigators.

Public health relevance
ADMINISTRATIVE, MENTORING AND EDUCATION CORE A Narrative The major goal of the Mississippi Center of Excellence in Perinatal Research (CEPR) is to develop an innovative, independent and sustainable center of excellence in perinatal research spanning the spectrum from adverse pregnancy to subsequent outcomes in offspring. Core A will provide administration, fiscal monitoring, and mentoring of project investigators with the aim to promote their development into NIH-funded investigators. The Core will administer the Pilot Projects Grant program, and the Mentoring and Education portion of this Core will provide education in various aspects of research, career development, and provide a process of formative and summative evaluations of the progress made by research project and pilot project investigators.